The Virtual Cadaver Lab: An Innovative Platform to Supplement Medical Education

[unreadable] DESCRIPTION (provided by applicant): Cadaver dissection is a critical exercise in medical education. In addition to the 60,000 plus medical students who participate in cadaver dissection, there are hundreds of thousands of other health care professionals and millions of high school students who would benefit from the exploratory learning experience that cadaver dissection provides. However, only 17,500 cadavers are available annually, and ethical and safety issues prevent such widespread use of what would otherwise be an invaluable educational experience in Anatomy. [unreadable] [unreadable] Over the past decade, personal computers have achieved remarkable performance milestones, driven by the gaming industry. An opportunity exists to develop a Virtual Reality anatomical exploration simulator that combines the best of virtual surgery and multimedia at an affordable cost and brings this invaluable experience to the masses. [unreadable] [unreadable] This proposal describes the Virtual Cadaver Lab, a 3D, real time, interactive exploratory application that allows students to explore the human anatomy the same way that medical students explore physical cadavers. VR offers distinct advantages over physical cadavers, such as the ability to erase mistakes, the ability to explore multiple specimens, the ability to record and playback dissections for assessment, and the ability to augment the experience with tissue and organ specific information. [unreadable] [unreadable] In the Virtual Cadaver Lab simulation, a student will be able to view a human body from any angle, touch it with a virtual probe, and cut open the skin for exploration. A low cost touch based input device is proposed that conveys the sensation of holding a scalpel while performing this dissection. [unreadable] [unreadable] The proposed Phase 1 research (to be followed by Phase II) has tremendous implications, not only for medical students, but for biology students at the K-12 and undergraduate levels. Medical students can practice on multiple cadavers as a supplement to their lab experience without the need to be present in a cadaver lab, and without regulatory or ethical issues. Other science students can gain valuable insight into the human anatomy by running the software in a schools' computer lab or on their home computer. [unreadable] [unreadable] [unreadable]